Resolving the intoxication mechanism of botulinum neurotoxins using single molecule structural biology

Abstract
We are requesting an Administrative Supplement for Equipment Purchases to obtain an AKTA Pure 25M
Fast Protein Liquid Chromatography (FPLC) System to replace our failing AKTA Purifier FPLC system
installed in 2007. The requested instrument meets all of our specific needs and will maintain
compatibility with our existing chromatography media and methods. The AKTA Pure 25M is capable of
detecting multiple wavelengths, which is essential when working with the fluorescent dyes needed for
single molecule experiments. The proposed system is capable of the full range of chromatography
methods in particular the low pressure columns we use for small scale purifications. The ability to
generate recombinant protein samples of high purity and then separate them from fluorescent dyes
forms the basis of all experiments under the parent award. This award was funded for 4 years starting
09/20/2023.

Public health relevance
The botulinum neurotoxins are some of the deadliest known yet are also revered for their pharmaceutical utility. These toxins are marvels of protein evolution able to inject a toxic cargo enzyme into a specific cell type using a self-contained delivery system. Our unique combination of expertise in single molecule imaging, molecular simulations and protein-engineering will allow us to answer long- standing questions about the delivery mechanism by overcoming the structural heterogeneity that challenged previous studies.